Brain-targeted delivery of therapeutic molecules by exosomes derived from engineered human iPS cells: a potential therapeutic approach for Huntington's disease

PROJECT SUMMARY
Huntington’s disease (HD) is a devastating neurodegenerative disease caused by a CAG repeat expansion in
the gene huntingtin (HTT). The CAG repeat is translated into a polyglutamine (polyQ) tract in the mutant HTT
protein that has neurotoxic properties. Current therapeutic efforts are focused at suppressing the expression of
the mutant HTT protein or targeting downstream pathways of neurotoxicity. We and others have shown that CAG
repeat-targeting phosphorodiamidate morpholino oligomers (PMOs) and neurotrophic protein BDNF have
therapeutic benefits for HD. However, PMOs and BDNF do not usually cross the blood-brain barrier (BBB),
hindering the translation of clinical application. Therefore, more efficient delivery vehicles capable of BBB
penetration are critical for the development of effective therapies for HD and other neurodegenerative disorders
in general. Exosomes (Exo) are cell-secreted extracellular vehicles with BBB penetration potential, capable of
delivering exogeneous therapeutic molecules. iPSCs have been considered as one of the best sources for Exo
manufacture, based on high Exo yield, availability of cGMP-compatible clinical-grade manufacture platform for
iPSC production and Exo manufacture, and feasibility to perform genome editing to establish engineered iPSCs
that produce modified Exo for more efficient brain targeting. We therefore propose to develop strategies to
produce brain-targeting Exo from engineered iPSCs as delivery vehicles for PMOs as well as BDNF, and further
rigorously study the therapeutic efficacy of the brain-targeting Exo loaded with PMOs and BDNF in a panel of
HD neuron and mouse models. Success of this project will set the stage for future larger scale investigations
aimed at using huma iPSC-derived Exo for targeted delivery of therapeutic molecules (such as PMOs, chemical
compounds and neurotrophic factors) for various neurodegenerative disorders.

Public health relevance
NARRATIVE It has been demonstrated that CAG repeat targeting phosphorodiamidate morpholino oligomers (PMOs) and brain derived neurotrophic factor (BDNF) are therapeutically beneficial for Huntington's disease, while their potential clinical application may be limited by their inability to cross blood brain barrier (BBB). However, human iPSCs produce abundant exosomes with considerable BBB crossing potential. We propose to generate engineered iPSC-derived exosomes for brain targeted delivery of PMOs as well as BDNF, and further evaluate its efficacy in suppression of mutant Huntingtin protein and neurotoxicity in HD striatal neuron and zQ175 knock- in mouse model.